IMAGING TELOMERE MAINTENANCE MECHANISMS IN GLIOMAS

PROJECT SUMMARY
All tumors, including gliomas, need a telomere maintenance mechanism (TMM) in order to
proliferate indefinitely and TMMs are, therefore, considered hallmarks of cancer. Primary
glioblastomas and low-grade oligodendrogliomas use reactivation of telomerase reverse
transcriptase (TERT) expression as their TMM while low-grade astrocytomas use the alternative
lengthening of telomeres (ALT) pathway. Due to their essential nature, TERT and ALT are
attractive therapeutic targets and, interestingly, studies indicate that TERT inhibition can lead to
resistance by induction of the ALT pathway. Our goal is to identify novel, magnetic resonance
spectroscopy (MRS)-detectable metabolic biomarkers of TERT and ALT in gliomas that will
enable non-invasive imaging of tumor burden and response to therapy. Our scientific premise
is that prior studies as well as our preliminary data, indicate that TERT and ALT are associated
with significant metabolic reprogramming, resulting in unique MRS-detectable metabolic
signatures of TMM status. Our specific aims are as follows: Aim 1- to identify non-invasive 1H-
and hyperpolarized 13C-MRS-based imaging biomarkers of TMM status in genetically-engineered
and patient-derived glioma cells; Aim 2- to determine the utility of 1H- and hyperpolarized 13C-
MRS for metabolic imaging of TMM status in orthotopic glioma xenografts in vivo; Aim 3: to
mechanistically validate our imaging biomarkers by identifying the molecular mechanisms by
which TERT and ALT alter metabolism in gliomas. This proposal is innovative because: 1)
although TMM have been linked to metabolic reprogramming, we are the first to propose to exploit
this link for non-invasive imaging 2) we have access to unique genetically-engineered and patient-
derived glioma models that differ in TMM status 3) we propose to use unbiased principal
component analysis to identify TMM-linked metabolic alterations and 4) we have access to and
expertise in the application of innovative, translational hyperpolarized 13C-MRS imaging methods
to brain tumors. This research is significant because the metabolic biomarkers identified here
will provide a non-invasive means of imaging TMMs, which are molecular features of brain tumors.
This will enable clinicians to distinguish tumor from regions of normal brain, edema or necrosis
and to monitor tumor recurrence and response to chemotherapy or radiotherapy. Identification of
imaging biomarkers tailored to TMM status will also allow detection of tumor response to novel
TMM inhibitors and the development of resistance to TMM inhibitors. Importantly, since TMMs
are a universal hallmark of cancer, our imaging biomarkers can potentially also be applied to
tumor types other than gliomas.

Public health relevance
PROJECT NARRATIVE Telomere maintenance mechanisms (TMMs) are molecular hallmarks of cancer and are linked to significant metabolic reprogramming in brain tumors. Our goal is to leverage this link to identify novel, translational, metabolic imaging biomarkers that can non-invasively inform on TMM status and, thereby, provide a means of distinguishing tumor from normal brain, edema or necrosis, of monitoring tumor recurrence, of tracking response to therapy including novel TMM inhibitors and of monitoring the development of resistance to TMM inhibitors. This research will, therefore, have the potential to significantly enhance quality of life and care for brain tumor patients.